Neurological pathophysiology of disrupted O-glycosylation in congenital disorders of glycosylation

PROJECT SUMMARY/ABSTRACT
Glycosylation is an essential, post-translational modification with complex and poorly understood roles in
protein function. My lab’s long-term objective is to elucidate the neurobiological functions of glycosylation,
including identifying the roles of critical glycosylation sites in neuronal protein function. The importance of
glycosylation is emphasized by the congenital disorders of glycosylation (CDG), a group of genetic disorders
that disrupt cellular glycosylation machinery. Affected patients exhibit severe neurological deficits, including
epilepsy and developmental delay. The genetic basis of CDG provides an opportunity to identify the
neurobiological functions of glycosylation using mouse models and human cells and organoids to identify and
manipulate glycosylation events to determine the roles of individual glycans on specific glycoproteins.
Understanding glycosylation in the nervous system will elucidate the pathophysiology of CDG and other
neurological diseases, enable therapeutic advances targeting glycosylation pathways, and inform normal
function of glycosylation.
GALNT2-CDG is a new CDG type caused by biallelic mutations in GALNT2, which encodes a critical
glycosyltransferase initiating the first step in mucin-type O-glycosylation. GALNT2-CDG patients suffer from
epilepsy and global developmental delay. Galnt2 whole body knock-out and conditional pan-neuronal knock-
out mice recapitulate many of the patient neurological deficits. My central hypothesis is that loss of site-specific
O-glycosylation in neurons impairs protein function contributing to the neurological deficits observed in Galnt2
KO mice and GALNT2-CDG patients. The specific objective of this proposal is to identify the roles of GALNT2-
mediated O-glycosylation in neurological function and disease. This will be achieved by genetically dissecting
the neurological circuit dysfunction in GALNT2-CDG cKO mice, using state-of-the-art glycoproteomics
advances in instrumentation, experimental methodologies, and computational approaches to identify O-
glycoproteome disruption, and determining the pathogenic impacts of disrupted O-glycosylation events using
human induced neurons (iNeurons) and brain organoids.
Successful completion of these aims will establish critical normal functions of GALNT2-mediated O-
glycosylation and elucidate glycosylation-related pathophysiology of human neurological diseases, potentially
enabling therapeutic advances.

Public health relevance
PROJECT NARRATIVE Glycosylation is an essential, post-translational protein modification with complex and poorly understood roles in protein function. This project utilizes a mouse model and human induced pluripotent stem cells differentiated into induced neurons and brain organoids to identify the cellular and molecular origin of neurological dysfunction in a rare disease (GALNT2-CDG) caused by genetic defects in a critical glycosyltransferase protein that initiates the first step in mucin-type O-glycosylation. Understanding glycosylation in the nervous system will elucidate the pathophysiology of rare genetic diseases that disrupt glycosylation (known as congenital disorders of glycosylation) as well as other neurological diseases, enable therapeutic advances targeting glycosylation pathways, and inform normal functions of glycosylation.